Effects of input quality on ASL vocabulary acquisition in deaf children

This research project aims to document the factors that shape the trajectory of language acquisition among
late signers, children who are learning a sign language and have early exposure to a rich language
environment but exhibit delays in early vocabulary development. Because there have not been assessments to
enable identification of late signers until recently, there are no studies documenting late signing. Under the
parent grant, we developed an assessment of early vocabulary, and administered it to a large number of deaf
children learning a sign language. From the data collected under the parent grant, we identified 51 deaf
children with early exposure to sign language who nevertheless had delayed early vocabularies. The project
has three specific aims: (1) to determine whether late signers go on to also have delays in ASL morphosyntax
and vocabulary, and identify possible socio-environmental predictors of trajectories among late signers, (2) to
compare effects of phonological neighborhood density in late and typically-developing signers, and (3) to use
spontaneous language samples to create in-depth receptive and expressive language profiles to document the
developmental sequelae of late signing. The proposed research is innovative in two ways. First, it seeks to
disentangle the effects of modality-specific characteristics of late talking from those that are language-general
or cognitive by documenting patterns of late signing. Second, this work will be the first empirical study
providing insight to families and providers about sign language delays that cannot be attributed to delayed
language exposure.

Public health relevance
The goal of this project is to document the characteristics of late signers—children who have early exposure to a sign language but have delays in early sign language vocabulary. This research has the potential to improve our understanding of late language acquisition, illuminating factors that may be general to all language acquisition from those that are specific to speech. Additionally, this work will support effective clinical practice, educational programs, and policies that support the language outcomes among children who are learning a sign language.